Novel Orally Available CBP/Beta-Catenin Antagonists to Treat Idiopathic Pulmonary Fibrosis

PROJECT SUMMARY/ABSRACT
Idiopathic pulmonary fibrosis (IPF) is a specific form of chronic, progressive fibrosing interstitial pneumonia
characterized by the formation of scar tissue within the lungs in the absence of any known cause. IPF is a
devastating disease with a poor prognosis and a median survival time of 2–4 years. The natural history of IPF is
heterogeneous and most patients follow a slowly declining clinical course after diagnosis. However, episodes of
acute respiratory worsening, are experienced by a significant minority.
Currently there are two drugs approved by the FDA for the treatment of IPF, Boehringer Ingelheim's
nintedanib and Roche's pirfenidone. Both drugs only modestly slow development of scar tissue in lungs of IPF
patients. However, neither can reverse nor even halt disease progression, as they merely serve to slow the
decline in patients' lung function. Therefore, there is a great unmet need to develop new therapeutics for IPF
patients that can minimally stabilize and potentially reverse the course of the disease. Additionally, many patients
with severe COVID-19 infections with comorbidities, subsequently develop pulmonary fibrotic disease1 and
activation of Wnt/β-catenin signaling is associated with ventilator- induced pulmonary fibrosis2.
IPF is a disease caused by injury to alveolar epithelial cells (AECs) with subsequent aberrant repair and
over activation of mesenchymal cells with the formation of fibroblastic and myofibroblastic foci. It is well
documented that Wnt/β-catenin signaling is important in the survival, migration, and proliferation of AECs and
activated Wnt/β-catenin signaling in fibroblasts increases migration, proliferation, and extracellular matrix (e.g.
collagen) production. However, the role of β-catenin signaling in fibrosis appears to follow a “Goldilocks” model,
where too little β-catenin signaling
in AT2 cells promotes epithelial
cell death thereby exacerbating
lung injury and fibrosis, whereas
aberrantly high β-catenin
signaling enhances the fibrotic
phenotype via fibroproliferation,
migration, and activation.
Furthermore, the fate of “good”
versus “bad” β-catenin signaling is
dictated by β-catenin’s differential
coactivator usage (Fig. 1)3.
Therefore, safe modulation of
Wnt/β-catenin signaling is a very
appealing therapeutic strategy to
treat pulmonary fibrosis. To date,
there are no such molecularly
targeted drugs that modulate
Wnt/β-catenin signaling and
differential Kat3 (i.e. CBP and
p300) coactivator usage, for IPF in
clinical trials.
The proposed research plan
outlines the development of a
potent and highly specific small molecule, orally available, CBP/β-catenin antagonist, [3+2]-517. This lead
compound and drug candidate demonstrates promising activity in the bleomycin induced mouse model of fibrosis
when dosed orally. The proposed research centers on in vivo evaluation of [3+2]-517 to reverse late stage
pulmonary fibrosis and to develop a highly efficient and convergent scale up synthesis for [3+2]-517 to serve
as the basis for GLP/GMP production of the API for IND-enabling toxicology studies and clinical batch for the
human phase 1 trial.
“GOOD”
ß-cat signaling
(p300/ß-cat)
“Bad”
ß-cat signaling
(CBP/ß-cat)
“Bad”
ß-cat signaling
(CBP/ß-cat)
Fig. 1. Model for ß-catenin signaling during lung injury, repair and fibrosis. Modified
figure from Cara J. Gottardi and Melanie Königshoff; Am J Respir Crit Care Med 2013
187566-568.

Public health relevance
Project Narrative Idiopathic pulmonary fibrosis (IPF) is a progressive and devastating disease with a poor prognosis and a median survival time of 2–4 years. Treatment options are limited with no drugs available to reverse or even halt disease progression. New agents are urgently needed that can safely ameliorate and reverse established lung fibrosis.